Development of a novel renalase agonist for the treatment of acute pancreatitis

Abstract
Acute pancreatitis (AP) is one of the leading gastrointestinal diseases leading to hospital
admissions worldwide, and of importance, there are no effective and approved drugs for AP. The
condition's morbidity is significant and closely linked to the severity of the disease. Early severe
complications of AP involve intense pain, persistent organ failure, and infections. The mortality
rate for those with severe disease during hospitalization is about 20%. There is a pressing need
for novel treatments for AP that can mitigate its severity, reduce pain, shorten hospital stays,
and decrease both morbidity and mortality. Current therapies for AP are supportive rather than
disease-specific, with a generic approach to pain management frequently involving opiates. A
treatment that could reduce the severity of AP and control the undesired inflammation while
simultaneously alleviating pain would make a substantial clinical impact, fulfill a significant
unmet medical need, and reduce healthcare costs.
Renalase (RNLS) is a novel plasma flavoprotein produced in the kidneys and other tissues with
pro-survival and anti-inflammatory effects. Yale has designed and developed a sensitive ELISA
assay that detects plasma RNLS and have shown levels significantly decline in animal models
and patients with AP. In preclinical studies, effective treatment of AP is achieved by
administering RNLS or a chemically synthesized peptide (BP-1002) that Bessor designed and
developed with RNLS-like activity. BP-1002 significantly decreases AP injury and pain in rodent
models in moderate and severe disease. The analgesic action is novel and non-opiate. An initial
4-day toxicology and toxicokinetic study in rats was completed with data indicating a promising
margin of safety. Funds from this grant, along with those of private investors, will be used to
complete all IND-enabling studies. These efforts include manufacturing of GMP BP-1002,
confirmation of biological activity in vitro and in vivo, development of further phase appropriate
analytical assays, formulation and stability studies, single and multi-dose toxicology and
pharmacokinetics studies in rats and dogs, cardiovascular safety studies in dogs, identification
of potential metabolites, and other necessary regulatory studies for an IND. The effects of BP-
1002 on inflammatory biomarkers will also be evaluated. With the completion of these studies,
an IND will be filed.

Public health relevance
PROJECT NARRATIVE Acute pancreatitis (AP) is the most frequent gastrointestinal cause of hospital admission in the U.S. exacting a severe toll of morbidity, high risk of follow-on diseases and mortality with hospitalizations costing more than $2 billion annually yet there are no effective and approved drugs. We discovered and others have confirmed that renalase is a naturally occurring protein functioning as a circulating pro-survival cytokine and immuno-inflammatory regulator that is deficient in animal models and patients and is linked to AP. The work supported by this grant advances to IND our unique chemically synthesized renalase agonist, BP-1002, which acts on the same receptor as RNLS, greatly reduces injury, inflammation, pain and improves survival in experimental models and with continued future success results in a highly effective new and extremely needed therapeutic.